#TranscendentHealth - Adapting an LGB+ inclusive teen pregnancy prevention program for transgender boys

Youth who are assigned female at birth (AFAB) and identify as transgender (e.g., as non-binary or as
trans boys), not as girls, are at risk for negative sexual health outcomes yet are effectively excluded from
sexual health programs because gender-diverse youth do not experience the cisgender, heteronormative teen
sexual education messaging available to them as salient or applicable. This lack of programming is likely
contributing to obstacles to sexual health: Data suggest that AFAB trans-identified youth may be less likely to
use condoms when having sex with people who have penises and are at least as likely as cisgender girls to be
pregnant. This health inequity must be addressed.
Access to inclusive sexual education, condoms, and sexual health support can vary widely across
regions of the US, and within states for those living in rural versus urban settings. This is particularly true now
that states have more influence on adolescents’ access to sexual health services and gender-affirming care.
Our comprehensive sexual health program will be developed nationally for maximal impact.
The foundation for this R01 proposal is our work with Girl2Girl, a text messaging-based sexual health
program designed for cisgender sexual minority girls 14-18 years of age. In an RCT of 948 LGB+ girls,
Girl2Girl was associated with higher rates of condom-protected penile-vaginal sex (f2=.11) and use of
birth control other than condoms (f2=.13)
at 12 months post-intervention.
We propose to adapt Girl2Girl to address social and structural influences of sexual behavior of AFAB
trans-identified youth, including significant social stressors, discrimination, dysphoria and rejection. In so doing,
this proposal addresses the National Institute of Nursing Research’s (NINR) research lens on HEALTH
EQUITY. It also speaks to NINR’s research lens on PREVENTION AND HEALTH PROMOTION across the
prevention continuum by including both sexually experienced and inexperienced youth. Specifically, we aim to:
Specific Aim 1: With ongoing feedback from trans-identified youth assigned female at birth,
adapt Girl2Girl for gender inclusivity to create #TranscendentHealth. First, we will conduct focus groups
(n=80) to identify and give voice to the contexts that affect sexual decision making of AFAB trans-identified
youth. After adapting the content, we will conduct Content Advisory Teams (CATs; n=50) to ensure that
program content resonates with these youth. Finally, we will conduct a beta test (n=22) to confirm the protocol.
Specific Aim 2: Test the resulting adaptation in a national RCT of 700 trans-identified AFAB
youth 14-18 years of age. Our main outcome measures will be: 1) Rates of condom-protected sex, 2) use of
other types of birth control methods (e.g., the shot, IUDs) other than condoms, 3) HIV/STI testing, and 4) PreP
uptake for those for whom it is indicated. Secondary measures also will include pregnancy, and intentions to:
1) use condoms, 2) uptake other birth control methods, 3) test for STIs and 4) uptake PrEP.

Public health relevance
Youth who are assigned female at birth (AFAB) and identify as transgender (e.g., as non-binary or as trans boys), not as girls, are at risk for negative sexual health outcomes yet are effectively excluded from sexual health programs because gender-diverse youth do not experience the cisgender, heteronormative teen sexual education messaging available to them as salient or applicable. This lack of programming is likely contributing to obstacles to sexual health: Data suggest that AFAB trans-identified youth may be less likely to use condoms when having sex with people who have penises and are at least as likely as cisgender girls to be pregnant. #TranscendentHealth aims to address this health inequity.